EVALUATION OF COOLING THERAPY FOR MULTIPLE SCLEROSIS

The overall objective is to quantify the effects of both acute and chronic cooling therapy on the objectively measured performance of patients with multiple sclerosis in a randomized, controlled, double- blind, cross-over study.